Development and Applications of Bioorthogonal Chemistry: Administrative Supplement for Equipment

Development and Applications of Bioorthogonal Chemistry: Administrative Supplement for Equipment
ABSTRACT
We have a long-standing interest in developing reactivity-based chemical tools to address significant biological
problems that are difficult to solve using conventional molecular biology techniques. In our MIRA application,
we plan to continue our studies of orthogonal chemical reactivity at the chemistry-biology interface and pursue
the following two related projects. In Project 1, we will construct the FRET-based biosensors of GLP-1R and
GCGR using bioorthogonal chemistry techniques. These biosensors will then be employed to probe the
conformational dynamics during the ligand-induced receptor activation and signaling in live cells. A new set of
fluorescence 'turn-on' reagents will be designed for bioorthogonal labeling of the intracellular loop 3 of GLP-1R
and GCGR to allow single-cell intra- and inter-molecular FRET analysis of receptor dynamics in live cells. In
Project 2, we will develop a genetically encoded chemical crosslinker containing an alkyne group and apply
this chemical crosslinker to map the time-dependent GLP-1R and -arrestins interactomes by mass
spectrometry in response to ligand stimulation. We expect these studies to validate new bioorthogonal tools for
real-time monitoring of protein conformation and protein-protein interactions in live cells. Also, we will gain
novel insights into the GLP-1R and GCGR activation dynamics and structural basis of biased signaling that are
crucial for the development of targeted therapies for the treatment of diabetes and obesity. This
Administrative Supplement requests the acquisition of an Agilent 1260 Infinity II LC System with Diode
Array Detector. This system will help us characterize the bioorthogonal reagents' reaction kinetics and
selectivity at higher throughput and greater accuracy.

Public health relevance
Development and Applications of Bioorthogonal Chemistry: Administrative Supplement for Equipment Narrative This application aims to develop and apply new reactivity-based chemical tools that, together with the genetic encoding of novel chemical functionalities, enable the construction of functional GPCR biosensors and capture the transient and highly dynamic GPCR-interacting proteins in living cells. This Administrative Supplement requests the acquisition of an Agilent 1260 Infinity II LC System with Diode Array Detector, which should help us characterize the bioorthogonal reagents' reaction kinetics and selectivity at higher throughput and greater accuracy.